Diverse Homeostatic Roles for Distinct Macrophages in the Developing Lung Vasculature

Alveolarization, the final stage of lung development occurring primarily postnatally, markedly increases
gas exchange surface area. Rapid growth of the pulmonary vasculature by angiogenesis during early
alveolarization drives distal lung growth, and disrupted angiogenesis impairs alveolarization. In other organs,
specialized macrophages support angiogenesis by promoting blood vessel formation, providing survival and
migratory cues to EC, and facilitating vascular anastomoses. However, the role of macrophages in the
developing pulmonary vasculature remains entirely unknown. We recently embarked on a project employing
single cell RNA-sequencing to define macrophage diversity during late embryonic and early postnatal lung
development. Macrophages are extremely heterogenous with diverse phenotypes that are lineage- and tissue-
specific, and highly influenced by the microenvironment. Preliminary data in this proposal demonstrate a
tremendous increase in macrophage diversity after birth. Specialized, highly proliferative macrophages present
before birth are replaced after birth by a complex and dynamic mixture of diverse macrophage subtypes
exhibiting unique gene signatures, developmental gradients in gene expression, and specific locations within the
lung suggesting distinct functions in tissue remodeling, angiogenesis, and immunity. Interestingly, a subset of
embryonic macrophages was found to completely encircle small arterioles and express numerous genes that
regulate lung branching, angiogenesis, and EC phenotype. After birth, these cells transitioned to an intermediate
subset present only during the first few weeks of postnatal life that expressed additional tissue remodeling genes.
Taken together, our data suggest the hypothesis that distinct macrophage populations support alveolarization
by regulating pulmonary vascular development through the expression of factors that influence vascular growth
and remodeling, which will be tested through three specific aims. Aim 1 will combine multiplexed in situ
hybridization, lineage tracing, studies in primary EC and macrophages, and advanced imaging in transgenic and
knock-out mice to define the role of specific macrophage subsets in modulating EC phenotype and regulating lung
parenchymal and vascular growth. Aim 2 will utilize multiplexed in situ hybridization, conditional knock out mouse
models, and ligand-receptor profiling of single cell datasets from pulmonary EC and macrophages to probe pathways
mediating macrophage-EC communication. Finally, Aim 3 will determine if chronic hyperoxia alters diversity and
phenotype of the lung macrophages during acute injury and after recovery, and specifically impairs
developmental and homeostatic functions of lung macrophages. The successful completion of these studies will
provide a multifaceted view of the diverse functions of lung macrophages during embryonic and early postnatal
development at single cell resolution, and identify new pathways that could be directly translated into novel
strategies to modulate vascular growth and regeneration in diseases marked by impaired pulmonary
angiogenesis.

Public health relevance
The formation of the distal air sacs (alveolarization) requires the development of blood vessels by the process of angiogenesis. Disruption of angiogenesis and alveolarization in infants causes bronchopulmonary dysplasia, the most common complication of premature birth. Our studies will explore if lung immune cells regulate angiogenesis in the developing lung, and identify new pathways to allow the development of therapeutic strategies to promote lung growth and regeneration in both infants and adults with lung disease.